Investigating the mechanism of decision-making in the mitochondrial Protease YME1

PROJECT SUMMARY
YME1 is an ATP-dependent protease located in the inner mitochondrial membrane, and plays a central role in
executing the functional activities of the mitochondrial protein quality control network. Preserving homeostasis
within the mitochondria is critical to maintaining cellular health and preventing a wide range of human diseases
resulting from the dysfunction of the mitochondria, including neurodegenerative diseases, cardiovascular
disorders, and cancer. YME1 is capable of proteolytically processing a wide variety of diverse mitochondrial
substrates through regulatory mechanisms that remain largely unknown. One of the most intriguing aspects of
YME1 proteolytic activity arises from its unique ability to perform molecular decision-making: YME1 can choose
to perform 1) processive degradation of a target substrate, whereby it cleaves the substrate into small peptides,
or 2) site-specific cleavage through which the substrate undergoes a single cleavage event and is subsequently
released by YME1. One of the most well-characterized of these site-specific cleavage functions is the cleavage
of the optical atrophy 1 (OPA1) protein, which is implicated in age-related eye disease, at an internal loop by the
human YME1 protein (YME1L). This cleavage event produces two isoforms of OPA1, the ratio of which is crucial
to regulating mitochondrial morphology and function. However, despite much investigation into the mechanistic
bases for molecular decision-making performed by YME1 proteins, the atomic drivers that distinguish between
these two degradation modes remain elusive. Yeast YME1 shares high sequence conservation with human
YME1L, especially at the catalytic sites, making it an excellent molecular model for investigating this substrate
processing mechanism. Interestingly, the site-specific cleavage of the yeast chaperone protein Tim10 occurs at
a site that shares high sequence conservation with that of human OPA1. Thus, insights gained from studies of
proteolytic processing in yeast YME1 have a strong potential to apply broadly to this mechanism in human
YME1L as well as related ATP-dependent proteases. This work will focus on elucidating the mechanistic details
that define how YME1 selects and distinctly processes protein substrates based on its sequence and folded
state. The details of this mechanism will be investigated in two Aims. The first aim will combine structural and
biochemical studies to examine how structural components of YME1 perceive and respond to specific sequences
within targeted substrates. The second Aim will explore how YME1 switches between processing modalities
based on a difference in the folding stability of the targeted substrate. These combined structure-function studies
will define the molecular underpinnings that regulate two distinct functional activities of an ATP-dependent
protease that are required for mitochondrial health. The outcomes of this study will provide a comprehensive
model of the regulation of proteolytic processing by YME1, that will enhance our understanding of human YME1L
function, and how perturbations of its function are associated with mitochondrial dysfunction and human disease.

Public health relevance
NARRATIVE Mitochondria are energy-producing components within our cells, and perturbations in their function are implicated in a wide range of human diseases, including neurodegenerative diseases such as Alzheimer's and Parkinson's, cardiovascular disorders, metabolic disorders, and cancer. I will investigate how one of the important proteins critical for mitochondrial health, YME1, makes molecular decisions about how it processes substrates in response to cellular stress and toxicity, using integrated structural, biochemical, and computational approaches.